Genome Technology Center Shared Resource

Abstract/Project Summary
GENOME TECHNOLOGY CENTER (GTC)
The Genome Technology Center (GTC) shared resource provides centralized, expert genomic
services to all Perlmutter Cancer Center (PCC) investigators at NYU Langone Health (NYULH).
Under the direction of Dr. Adriana Heguy, a recognized expert in genomic analysis, GTC is a
state-of-the-art, high throughput, fast turnaround, fully equipped genomic facility, specializing in
both short-read (Illumina) and long-read (PacBio, Oxford Nanopore Technologies) deep
sequencing and sample preparation for a variety of applications including RNASeq, ChIPSeq,
ATACSeq, bisulfite sequencing, single cell sequencing, chromatin conformation sequencing
approaches, and many others. The GTC mission is to foster cross-institutional science by
providing highly specialized support in a collaborative environment that results in successful
grant applications and publications. GTC provides affordable access to technologically
advanced services and instrumentation, and an educational environment for faculty, staff,
fellows, and students in the PCC who are interested in learning how these technologies can
advance their basic and clinical cancer research. The Specific Aims of GTC are: Aim 1) To
provide expert genomic services; Aim 2) To evaluate and implement novel genomic technology
and thereby maintain state-of-the-art services; Aim 3) To facilitate data sharing and storage
through high performance computing secure servers; Aim 4) To assist the CLIA-certified NGS
laboratory in technology development and validation; Aim 5) To educate and inform members of
the PCC communities on genomic technologies and their utility for cancer research.